Post-Doctoral Training in Intellectual and Developmental Disabilities Research

PROJECT SUMMARY/ABSTRACT
Since 1995, the University of Wisconsin-Madison's Waisman Center Postdoctoral Training Program in
intellectual and developmental disabilities (IDD) Research has provided inclusive and high-quality training to
foster the next generation of leaders in IDD research. The program emphasizes interdisciplinary and
translational research on IDD, with a focus on socioemotional, cognitive, motor and communication domains.
To date, 57 postdoctoral scholars have completed the program, of whom 40 obtained tenure-track faculty
positions, and virtually all others are in research-intensive leadership roles with relevance to advancing IDD
science. Our trainees have had tremendous success in authoring high-impact publications and securing NIH
and other federally-funded grants in addition to foundations grants. The training program is integrated into the
Waisman Center's broader array of interdisciplinary and translational training activities, including those offered
through their NICHD-funded Intellectual and Developmental Disabilities Research Center (IDDRC). The 18
program faculty trainers represent eight different departments or schools on UW-Madison's campus. These
faculty trainers are committed to promoting a diverse and high-quality training program and serve as the PI or
Co-I on 42 active research grants from NIH and other federal agencies. The overarching goal of the program is
to provide interdisciplinary biobehavioral and translational research training to foster future IDD research
leaders. The program includes a core curriculum and individualized career development activities that provide
trainees with a broad foundation of IDD knowledge (e.g., prevalence, etiology, presentation, and social
determinants of health) and the skills for engaging in ethical science that is rigorous and replicable. The
trainees are also equipped with professional development for publishing, obtaining research funding, managing
research projects, and being in leadership positions. By working closely with program faculty trainers, the
trainees learn research methods and analytic skills to launch their own independent lines of research. Trainees
develop individual development plans and establish specific, measurable, achievable, and time-bound
research and professional goals to focus their two years. The program has four learning objectives: 1) Develop
a broad interdisciplinary foundation of knowledge on IDD (e.g., prevalence, etiology, presentation and social
determinants of health); 2) Gain the needed expertise in an area of IDD research to advance science; 3)
Understand key issues of research ethics and the policies and procedures that govern research practices; 4)
Obtain the research and professional development skills needed for a research career in IDD including grant
writing, manuscript writing, and research management. The program has been successful in creating a diverse
training environment and is well-positioned to prepare the next generation of researchers with the skills for
addressing the problems of critical importance to the IDD community.

Public health relevance
PROJECT NARRATIVE The Waisman Center Postdoctoral Training Program in Intellectual and Developmental (IDD) Research program provides interdisciplinary biobehavioral research training on IDD with the goal of preparing trainees for a career in this area. The prevalence of IDDs is on the rise and now estimated to effect nearly 1 in every 11 children in the United States; thus, there is an urgent and significant need to grow the scientific workforce of researchers with expertise in IDD who can advance science related to the etiology of IDDs and interventions to promote optimal development and quality of life of people with IDD. The program has a demonstrated track record of success as evidenced by trainee success in authoring publications in top-tier journals, securing research awards from NIH and other federal sources, and obtaining research-intensive positions.